Glutathione depletion in the CNS and its effects on Mtb infection

Project Summary:
Tuberculous Meningitis (TBM) is the most severe form of extrapulmonary tuberculosis (TB) and is associated
with significant morbidity and mortality in humans worldwide. Individuals with TBM show a marked
deficiency in the levels of glutathione (GSH), the principal non-protein thiol responsible for cellular
homeostasis and maintaining the intracellular redox balance. Since the current anti-TB regimen is
formulated for pulmonary TB, they are not optimal for treating TBM. Thus, adjunctive immunotherapy is a
promising approach to improving the clinical outcome of refractory mycobacterial infections in these cases.
We have reported that GSH has direct antimycobacterial activity in vitro and at physiological
concentrations. In combination with cytokines such as IL-2 and IL-12, GSH enhances the functional activity
of natural killer (NK) cells to inhibit the growth of Mycobacterium tuberculosis (Mtb) inside human monocytes.
Similarly, GSH activates the functions of T lymphocytes to control Mtb infection inside human monocytes. In
our previous R15 award, we demonstrated that GSH deficiency in the lungs resulted in increased Mtb burden
in the lungs and spleen. Furthermore, GSH restoration resulted in favorable immune responses in the lungs
leading to improved control of Mtb infection. Importantly, we reported that GSH has additive effects in
improving the ability of rifampicin (RIF) to control Mtb infection. Put together, our findings 1) unfold a novel
and potentially important innate defense mechanism adopted by human macrophages to control Mtb
infection and 2) indicate that GSH controls Mtb infection by functioning as an antimycobacterial agent as well
as by enhancing the effector functions of immune cells. However, the underlying mechanisms by which
GSH deficiency alters the immune responses leading to increased susceptibility to TBM remains
unknown, and the potential use of GSH as a possible therapeutic agent for TBM remains untapped.
The translational aspect of the studies proposed in this grant application may lay the foundation for the
development of adjunctive pharmacotherapy to improve TBM treatment. Our long-term goals are to acquire a
detailed understanding of the pathogenesis of TBM in various settings such as in pediatric subjects and in
those with HIV infection and develop novel therapies to combat TBM.

Public health relevance
Project Narrative: Tuberculous Meningitis (TBM) is the most severe form of extrapulmonary tuberculosis in humans worldwide. Delay in the treatment or sub-optimal treatment of TBM cases results in either death or substantial neurological morbidity. Studies proposed in this application will unfold the pivotal mechanisms involved in protection against TBM and will specify whether glutathione can be used as a promising adjunctive immunotherapeutic agent to prevent the development of TBM.